Maryland Occupational Health and Safety Surveillance Project

? DESCRIPTION (provided by applicant): In partnership with other State agencies and non-governmental organizations, the Maryland Department of Health and Mental Hygiene (DHMH) seeks to create an expanded Occupational Health and Safety Surveillance Project (OHSSP), focused on three overall projects: (1) improving and expanding the occupational health indicators (OHIs) reported in the previous project period, including creating more opportunities to use the occupational health indicators in a variety of settings to improve health and safety outcomes for workers in Maryland; (2) re-establishing a fatality assessment, control and evaluation (FACE) program within the Occupational Health and Safety Surveillance Project to improve data related to occupational fatalities; and (3) addressing the issue of the potential role of prescription pain medication in occupational health and safety in the State, with a project that focuses on improving data (including the State's new Prescription Drug Monitoring Program) and utilizing those and other data with an educational online training program.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project has significant implications for the health of Maryland workers and for the national workforce. It uses enhanced state surveillance data to improve ongoing education and outreach prevention programs. Moreover, the focus on prescription pain medication may improve our understanding of the role of pain medication in occupational injuries and fatalities, as well as evaluating possible strategies for their control.